Development of a novel device for diabetic wound healing using high-frequency, low amplitude vibration

Project Summary
Diabetic foot ulcers (DFU) pose a considerable healthcare burden, impacting a large population and incurring substantial
Medicare expenses. Given the limited array of available treatments, there is a clear demand for innovative approaches.
Existing methods for DFU management, although diverse, frequently do not augment blood flow, a vital element in the
wound healing process. In the short term, our objective is to utilize HFLAV to determine the healing time of stage 2 DFUs
and evaluate their impact on quality of life (QOL) when compared to conventional standard of care approaches. Our long-
term vision is to refine HFLAV protocols for application across a broad spectrum of diabetic wounds, regardless of
associated comorbidities, and enhance the physical well-being of diabetic patients. Our central hypothesis posits HFLAV
has the potential to reduce the time required for stage 2 DFUs to heal by as much as 30% while concurrently enhancing
QOL scores. This hypothesis draws upon a comprehensive understanding of vascular endothelial physiology and
previously published research findings. The underlying rationale is that expediting the healing process of stage 2 DFUs
can serve as a foundation for addressing diabetic wounds comprehensively and alleviating the economic burden associated
with wound care. Our research will revolve around two main objectives: (1) Enhance and validate the Driver device by
incorporating thermography to measure blood flow and tissue heat depth. Ensure it meets ISO safety standards for Phase
I-II development; and (2) Conduct a small R01 clinical trial to evaluate the safety and efficacy of the Driver device in
diabetic ulcer patients. These aims collectively aim to improve diabetic wound healing and enhance the overall well-being
of diabetic individuals. The proposed research is significant because accelerating stage 2 DFU healing could potentially
save up to $2000 per month in outpatient healthcare costs, offering significant financial relief, considering the large
diabetic population and ulcer prevalence. Additionally, the significance of this study for patients lies in the potential to
offer a more efficient, less painful, and cost-effective approach to healing diabetic foot ulcers, ultimately improving the
lives of those affected by this condition. The outcomes will have an important impact because of its potential to
significantly improve the management and treatment of diabetic foot ulcers. This research serves as a foundational step in
advancing the treatment of diabetic wounds, offering opportunities for further investigation, optimization, and the
development of patient-centered approaches to wound management. It paves the way for future studies and innovations
aimed at improving the health and well-being of individuals with diabetic foot ulcers and other diabetic wounds.

Public health relevance
PROJECT NARRATIVE This research project seeks to pioneer an innovative approach in diabetic wound care by investigating the efficacy of high-frequency, low-amplitude mechanical vibration (HFLAV) in expediting the healing of diabetic foot ulcers (DFUs) and aligns with the mission of the National Institute of Diabetes and Digestive and Kidney Diseases. Through an innovative approach and a clinical trial, this study aims to examine the impact of HFLAV on DFU healing times and patients' quality of life to significantly enhance patient outcomes and reduce the healthcare burden associated with diabetes-related ulcers.